Impaired Mitochondrial Energetics is a Driver of Hemodialysis Access Related Hand Dysfunction

PROJECT SUMMARY
Currently, in the United States, there are ~425,000 patients receiving hemodialysis (HD) and it is estimated that
30-60% of this population have some element of hand dysfunction after hemoaccess surgery. The underlying
pathophysiologic mechanisms responsible for this devastating problem are poorly understood. The renal
dysfunction (RD) milieu causes a variety of physiologic derangements in HD patients including increased
oxidative stress (OS) and chronic inflammation that have been implicated as major contributors to accelerated
atherosclerosis and elevated mortality. Profound changes in OS contribute to skeletal muscle and neuromuscular
junction dysfunction associated with muscle atrophy and frailty in this population. AVF surgery causes significant
hemodynamic changes in the extremity which presents an adaptive challenge to the skeletal muscle and
neuromotor end-plate. Supported by our previous work, as well as preliminary data on RD associated skeletal
muscle mitochondrial phenotypic changes, we propose that RD driven mitochondrial dysfunction alters skeletal
muscle and neuromuscular junction responses to AVF induced ischemia leading to clinically apparent hand
dysfunction. Further, these pathways can be modified either prior to AVF creation or at first evidence of hand
dysfunction to reverse/prevent the functional impairment. Our hypothesis is that the RD milieu disrupts
mitochondrial and cellular energetics resulting in elevated OS predisposing patients undergoing AVF surgery to
developing skeletal muscle and neuromuscular junction perturbations causing clinically significant hand
dysfunction. RD mediated mitochondrial impairments are further exacerbated by local hemodynamic changes
following AVF creation through maladaptive OS metabolic responses that drives the diversity of clinically
apparent hand dysfunction. Aim 1 will establish how RD impacts mitochondrial and cellular energetics that are
exacerbated by AVF-induced limb ischemia. Using a series of in vitro experiments, we will uncover the
biochemical mechanisms by which RD impacts mitochondrial energetics leading to impaired oxidative
phosphorylation and increased OS. Aim 2 will determine the efficacy of global or mitochondrial-targeted
antioxidant therapies delivered prior to- and following AVF surgery in mice. Using a novel RD murine AVF model,
we will determine whether global (N-acetylcysteine) or mitochondrial-targeted (AAV delivery of mitochondrial
targeted catalase) antioxidant therapy have therapeutic potential for AVF-induced muscle dysfunction. Aim 3
will evaluate the association between mitochondrial health and AVF-induced hand dysfunction in human
patients. Mitochondrial health will be examined in-situ using permeabilized myofibers prepared from RD patients
before and after AVF surgery: mitochondrial phenotypic changes will be evaluated and their association with
changes in serial hemodynamic, neurophysiological and biomechanical outcomes modulating the spectrum of
hand function will be determined.

Public health relevance
NARRATIVE Approximately half of all patients who receive an arteriovenous fistula for hemodialysis access will development some element of hand dysfunction. This proposal seeks to understand the basic mechanisms of how renal dysfunction associated oxidative stress leads to muscle and nerve mitochondrial dysfunction that is exacerbated by arteriovenous fistula induced ischemia. Moreover, novel therapeutic anti-oxidant therapies will be tested in animal models and observations from mechanistic studies will be correlated with clinically measured neuromuscular dysfunction in patients undergoing hemodialysis fistula surgery.